Genetics of Zebrafish Hair Cell Toxicity

PROJECT SUMMARY
The vast majority of hearing and balance impairments are thought to be due to death of sensory hair cells, the
receptor cells of the inner ear. These cells are unusually metabolically active and hypersensitive to damage
from overstimulation, exposure to some therapeutic drugs and environmental toxins, and to aging. Growing
evidence indicates that hair cell loss from gram-negative antibiotics, antineoplastic drugs, excessive noise
exposure and possibly aging share some common cellular pathways. The goals of our research program,
requesting continued funding for Years 16-20, are to understand the pathways that regulate death and survival
of inner ear hair cells, and to use this information to facilitate development of therapeutic agents to prevent
hearing loss. Three groups of experiments are proposed: a) determine roles of the lysosome in both promoting
and preventing damage caused by aminoglycoside antibiotics; b) identify the cellular mechanisms and
molecular targets of a new therapeutic drug that protects hair cells against antibiotic-induced ototoxic damage;
and c) test whether this new therapeutic will protect in vivo against cisplatin toxicity. An assumption of our
work is that highly conserved properties of HC function render them unusually vulnerable to antibiotic and
antineoplastic drug toxicity. Thus, in addition to clinical implications for preventing hearing and balance
disorders, these studies may also reveal important aspects of normal HC function that give rise to their
vulnerability.

Public health relevance
PROJECT NARRATIVE In the US, over 36 million adults have trouble hearing. There are a variety of causes but no clinically proven treatments to restore normal hearing or prevent hearing loss. Our research will reveal how the sound sensing cells of the ear are damaged, identify pathways that may underlie the variation in susceptibility to hearing loss, and discover drugs that may prevent hearing loss.